Hippocampal-dependent neural immune interactions regulate heroin withdrawal and future enhanced fear learning

Project Summary
Opioid use disorder is a national crisis, and multiple lines of evidence indicate that heroin use leads to increased
incidence and severity of anxiety disorders, including post-traumatic stress disorder (PTSD). Our laboratory has
established a preclinical model that effectively demonstrates heroin withdrawal-induced hyperreactivity to future
stressors, one of the key components of human PTSD. We discovered that withdrawal from escalating heroin
administration results in an increase in dorsal hippocampal (DH) interleukin-1β (IL-1β), and blockade of DH IL-1
with receptor antagonist (IL-1RA) prevents heroin withdrawal enhanced fear learning. This IL-1β is expressed
predominantly in astrocytes, and heroin withdrawal also upregulates glial fibrillary acidic protein (GFAP)
expression, a marker for astrocyte reactivity. This suggests that astrocyte signaling may be involved in heroin
withdrawal and future enhanced fear learning, however it is presently unknown whether there is a causal link
between the two. The current proposal is a targeted approach to test the overall hypothesis that heroin withdrawal
enhances fear learning through DH astrocyte signaling and alterations in astrocyte physiology. Aim 1 tests the
hypothesis that DH astrocytes mediate heroin withdrawal-induced enhanced fear learning. We have successfully
implemented Gi-coupled designer receptors exclusively activated by designer drugs (Gi-DREADDs) into our
research program to manipulate the DH astrocyte signaling in vivo. Aim 1 tests if astroglial GPCR signaling is
capable of influencing the long-term effects of heroin withdrawal on enhanced fear learning. In Aim 1, I will be
trained in chemogenetic techniques, acquire extensive knowledge of this cutting-edge tool, and become
proficient in using glial DREADDs to investigate how astrocyte signaling relates to behavior. Results will
establish that DH astroglial signaling during heroin withdrawal mediates changes in the development of long-
term fear. Aim 2 tests the hypothesis that heroin withdrawal alters DH astrocyte morphology and astrocyte-
neuron interactions. We have established a method to analyze the complexity of individual astrocytes using the
AAV5-GFAP-Lck-GFP construct, high-resolution confocal microscopy, and advanced analysis of 3-dimensional
cellular reconstructions. Using this innovative technique, we will examine the effect of heroin withdrawal on
astrocyte morphology and colocalization with post synaptic markers, a proxy for astrocyte-neuron interactions.
In Aim 2, I will refine and enhance my skills in IHC, confocal microscopy, and advanced cellular analysis using
the Bitplane Imaris software to quantify withdrawal-induced changes in astrocyte morphology and synaptic
interactions. Results will establish that heroin use and withdrawal directly alters DH astrocyte physiology that
may lead to enhanced fear learning and anxiety. Collectively, this proposal examines the role of hippocampal
astrocytes in mediating enhanced fear learning following heroin withdrawal. These studies make important
contributions to understanding the effects of heroin withdrawal on astrocytes and provide a valuable learning
experience to foster the independence of my research career in addiction neurobiology.

Public health relevance
Project Narrative The project will provide important new information about the neural mechanisms by which heroin withdrawal leads to enhanced fear. The research focuses on the role of the astrocytes in the brain as the critical mediator of the heroin withdrawal effect on future fear learning. The project has the potential to inform the development of novel neuroimmunological treatment approaches to prevent long-term behavioral consequences of heroin use.